The role of lung lipofibroblasts in alveolar differentiation

Abstract
A complication of preterm birth is underdeveloped lungs that lack surfactant and adequate gas
exchange due to immature alveoli. Although recent advances have been made, the process of
alveolar maturation is not well understood. A goal of this project is to understand signaling
from mesenchymal cells that direct alveologenesis, the final stage of lung development. We
have found that disruption of a specialized fibroblast, the lipofibroblast, results in reduced type
II alveolar cell differentiation. Type II alveolar cells are responsible for surfactant production,
and we will investigate the communication between lipofibroblasts and alveolar cells during lung
development in the mouse. The lipofibroblast has been a difficult cell to identify, and little is
known about the function of these cells. Our preliminary data demonstrate that a transcription
factor is required for the development of lipofibroblasts and alveolar differentiation. Based upon
these preliminary findings, we hypothesize that lipofibroblasts are required for the later steps of
lung development and that they secrete growth factors that are required specifically for terminal
differentiation of type II alveolar cells. We will investigate these cellular interactions in two
specific aims. In specific aim I, we will determine how lipofibroblasts impact alveolar
differentiation by examining the temporal requirement for lipofibroblasts and by evaluating
postnatal lung development in mice lacking lipofibroblasts. In Specific Aim II we will use in
vitro organoid culture and gene expression profiling to explore the lipofibroblast cellular signals
that direct type II alveolar differentiation. Together these aims will define the role of the
lipofibroblast and potentially identify therapeutic targets for increasing the rate of type II alveolar
differentiation in preterm births.

Public health relevance
One complication of premature birth is airway collapse, known as respiratory distress syndrome. This condition is cause by underdeveloped alveoli, and the goal of this project is to better understand the cellular signals that guide postnatal lung development. Information gained in these studies may lead to improved treatments for lung maturation and reduce the amount of time that infants spend on ventilators.